Identifying neural fingerprints of suicidality

Death by suicide has been steadily increasing in the last 20 years, and the social isolation and financial stress
associated with the current pandemic may unfortunately provide the perfect conditions for a dramatic
increase in suicidality. This risk is elevated among veterans, particularly those with traumatic brain injury
and psychiatric diagnoses, and the current public health crisis has alarming implications for mental health.
Current suicide prevention practices are largely informed by the evaluation of suicidal thoughts and
behaviors (STBs), and other clinical characteristics. One significant limitation in suicide risk and prevention
is the exclusive reliance on self-report, which is severely limited in its effectiveness to predict future suicide
attempts and deaths, and does not identify individuals who do not disclose thoughts or acts of self-harm. To
test an alternative to current modes of prevention, we propose that complementary neuroimaging-
based biomarkers of suicide risk can improve the identification of at-risk individuals.
DESIGN AND METHODS. Our lab is a leader in the application of cognitive neuroscience tools toward
precision psychiatry. We accomplish this by acquiring functional MRI, known to be consistently reproducible
within an individual but subject to great variability across individuals, making it unique to the person, as well
as their neuropsychiatric and neurocognitive profile. In this proposal, we will use these scans to parse out
brain connections across large-scale networks including emotional and inhibitory control circuitry that are
implicated in STBs. Then, by applying machine learning techniques, we will isolate the pattern of brain
activity that identifies suicidal individuals. Further, we will validate these neural markers of STBs by
collecting new fMRI data from veterans at risk for suicide while they perform the Suicide Implicit Association
Test (S-IAT), an objective behavioral measure known to predict future suicide attempt. Finally, we will
determine if these neural markers of STBs are also associated with impaired daily and social functioning, a
contributor to STBs. This will be one of the first studies to leverage these methods towards the goal of
identifying individuals at risk for suicide. The proposed study will accomplish these aims using both existing
neuroimaging and clinical data from the Translational Research Center for TBI and Stress Disorders, as well
as ongoing data collection in which 60 additional veterans will complete the S-IAT with concurrent fMRI.
OBJECTIVES. Aim 1: Develop a neuroimaging-based model to detect individuals with current suicidal
ideation and/or a history of suicide attempt(s). Hypothesis 1. Model will distinguish suicidal individuals
from those who are not suicidal but who have comparable mental health conditions, based on functional
connectivity between brain regions associated with emotional regulation and inhibitory control.
Aim 2: Determine if the cross-sectional model from Aim 1 can predict which individuals will attempt
suicide in the next 1-2 years. Hypothesis 2. Model will identify at least 50% of individuals who will
attempt suicide from those with comparable mental health conditions who will not attempt suicide.
Aim 3: Determine if the expression of the STB neural markers is associated with reduced functional
outcomes. Hypothesis 3. Neural markers of STBs will be associated with reduced functional outcomes.
Aim 4: Determine fMRI activation-based markers of STBs using the S-IAT. Hypothesis 4. Veterans with STBs
will have higher associations between “me” and “death” alongside greater activation in brain regions associated
with emotional regulation and inhibitory control.
IMPACT. Successful identification of a neural signature of suicidality would remove reliance upon self-
disclosure of suicidal thoughts and have dramatic clinical impact upon the precise identification and
prevention of suicidality. Future studies will then focus on validation of these biomarkers in independent,
prospective samples, as well as circuit-specific brain stimulation interventions targeting these biomarkers.

Public health relevance
This proposal will develop a new set of neuroimaging analysis methods to determine if suicidal thoughts and behaviors have specific brain signatures and whether these brain signatures can predict future suicide attempts. Developing and determining the feasibility of this neural modeling approach in our veterans has wide-ranging applications, including diagnostics, discovering brain targets for interventions, and predicting future outcomes. The proposed studies will serve as foundational methodological development, stimulating future research that will help our veterans improve their quality of life and behavioral health.